ROLE OF LAMININ BINDING PROTEINS IN HUMAN CANCER

"The interaction of the tumor cell with its extracellular matrix may play an important role in determining its metastatic and invasive properties. We have identified, isolated, and characterized cDNA clones of the human and the mouse 37 kDa laminin receptor precursor (37LRP) of the 67 kDa high affinity laminin receptor (67LR). The 67LR is expressed to a greater degree in metastatic tissues than in benign conditions in a variety of tissue-specific neoplasms. The 37LRP contains a laminin binding site that is conserved throughout evolution in organisms that either synthesize or bind to laminin. Prokaryotic and invertebrate homologs of the 37LRP have ribosome binding activity. It is presumed that vertebrate 37LRP proteins are multifunctional with both laminin- and ribosome-binding properties. The human and chicken 37LRP genes were recently cloned and analyzed. Human and chicken genes have the same exon-intron structure. The human gene was localized to chromosome 3p, band 21 and contains 7 exons that span 6 kb. The 5' region that flanks exon 1 does not contain a TATA box but contains other regulatory motifs including five Sp1 sites, a glucocorticoid responsive element, an AP1 site, and a metal responding element. Intron 1 is GC rich and contains seven Sp1 sites, suggesting it may participate in the regulation of 37LRP gene expression. Like many genes that encode ribosome binding proteins, intron 4 of the human gene contains the full sequence for a small nucleolar RNA."